Targeting the Pial Collateral Circulation for Mitigation of Cerebral Ischemia

DESCRIPTION (provided by applicant): Occlusive vascular disease of the brain, heart and lower extremities is the primary cause of morbidity and mortality in the US. Native (pre-existing) collaterals interconnect adjacent arterial trees and function as critical bypass vessels if obstruction occurs in one of the trees. Attention over the past 25 years has been on mechanisms mediating outward remodeling of collaterals in ischemic disease. However, until our work over the last three years, nothing was known about what controls the number and diameter (extent) of these vessels. We have shown that collateral extent in murine brain and other tissues varies widely due to genetic polymorphisms, resulting in a greatly increased risk-severity for ischemic injury of brain and other tissues in individuals having low collateral extenta finding recently confirmed in humans. We have discovered the major genetic locus, Candq1, responsible for most (70%) of this variation. We now seek to identify the polymorphic gene underlying this locus and its downstream effector pathway that regulate collateral formation. Aim I will fine-map Candq1 in a congenic strain-set that we have partly completed generating in preliminary studies: We will introgress informative partitions of the Candq1 locus of the C57BL/6 high-collateral strain into the BALB/c strain that has few-to-no collaterals in brain and other tissues. These congenic lines will then be phenotyped for collateral extent in brain and skeletal muscle, followed by functional analysis in a model of ischemic stroke in the positive congenic line(s) (+CNG) that most tightly partitions the causative region of Candq1. Aim II-A will additionally narrow the candidates by determining gene expression in the +CNG using RNA-Seq across Candq1, and also across the whole genome to identify potential downstream effectors. Aim II-B will further refine the candidates and targets, plus determine if a variant in cis/trans regulatory element underlies Candq1, using whole-genome chromatin mapping for active DNA regulatory sites. Aim I and II will thus identify the highest priority candidates that Am III will test for causality using in vivo gene targeting, cellular analyses, and functional outcomein stroke. This project will identify the primary driver gene that controls formation of the native collateral circulation and is responsible for its wide variation. Defining the gene underlying Candq1, and its downstream signaling effectors, will also pinpoint targets to develop as therapies aimed at inducing new collaterals to form in adults with few and/or who are at risk for or have suffered acute stroke or other cerebral ischemic conditions and diseases. Identifying this major allele that when polymorphic impairs collateral formation may also provide a genetic marker for use in these same patient groups.

Public health relevance
PUBLIC HEALTH RELEVANCE: While occlusive vascular disease of the brain, heart and lower extremities is the primary cause of morbidity and mortality in the US, native (pre-existing) collaterals that interconnect adjacent arterial trees provide the first line of defense by acting a endogenous bypass vessels when a stroke or heart attack occurs. Our work has discovered that the abundance of native collaterals in brain and other tissues varies widely as a function of genetic background, resulting in greatly increased severity of stroke and infarct volume in models of these diseases in mouse strains that have few collaterals; recent reports in human brain and heart support these findings. We have identified the major risk locus on mouse chromosome 7 that is responsible for much of this variation, and now seek in this proposal to define the causal gene and its effectors, thus establishing the main driver gene and downstream signaling candidates that control formation of the native pial collateral circulation in the embryo and, potentially, formation of new cerebral collaterals in adults suffering acute stroke and other cerebrovascular ischemic conditions and diseases.